Resilient Communication Systems: A Pediatric Patient Safety Learning Lab

PROJECT SUMMARY/ABSTRACT
Estimates suggest that nearly 1 in 10 hospitalized children may experience a safety or harm event, and
communication breakdown is a leading contributor to patient safety and harm events. A 2010 study estimated
that inefficient clinical communication cost US hospitals an estimated $12 billion annually in wasted clinician
time and increased lengths of stay. The introduction of technologies such as smartphones and secure text
messaging are transforming how, when, and what acute care clinicians communicate among each other.
Developing an infrastructure to proactively evaluate these systems, and build their resilience, is critical. The
goal of this project is to create a novel, nurse-led Pediatric Patient Safety Learning Lab with the objective of
reengineering interprofessional (e.g., nurse-physician) communication work systems for pediatric acute care
settings. The Learning Lab will consist of a multidisciplinary team of clinician-researchers, human factors
engineers, human-centered design experts, and operational safety experts from Children's Hospital of
Philadelphia and the University of Pennsylvania. We will also engage stakeholders, including bedside clinicians
and families of hospitalized children, whose experience of care may be altered by changes to how clinicians
communicate. We will use a systems engineering approach (Problem Analysis, Design, Development,
Implement, and Evaluate) to proactively assess the interprofessional communication work system, processes,
and outcomes, to identify opportunities for improvement before safety events occur. The Specific Aims of this
project are to (1) Conduct a problem analysis of the interprofessional communication work system and work
processes used in the care of hospitalized children; (2) Design and develop interventions to engineer a safer,
more effective, and more resilient interprofessional communication work system; (3) Implement and evaluate
the interventions in the clinical environment to gauge real-world impact. Our Learning Lab will be guided by two
frameworks, the Systems Engineering Initiative for Patient Safety model and the Integrated Resilience
Attributes Framework. The product of this Learning Lab will be a resilient system for interprofessional
communication, one that can positively adapt in the face of anticipated and unanticipated changes and
maintain the safety of care provided during the estimated 2.5 million pediatric hospitalizations each year.

Public health relevance
PROJECT NARRATIVE Millions of children are hospitalized every year and many will experience unintended harm caused by a breakdown in communication between the multiple clinicians caring for them. This Pediatric Patient Safety Learning Laboratory will develop interventions that help clinicians, such as nurses and doctors, communicate more effectively. The findings from our Learning Laboratory will be relevant to all hospitalized children because communication between clinical teams is essential for safe, effective, and high quality care.